Identification of a novel pathway that regulates optic nerve myelination and remyelination

Project Summery
In the optic nerve, oligodendrocytes (OLs) are sole myelin-producing cells. Myelin provides insulation
and trophic support for RGC axons and allows for normal vision. Death of OLs and demyelination in the optic
nerve are the hallmarks of demyelinating diseases that often impair vision, including optic neuritis and multiple
sclerosis. The signaling mechanisms that controls OL survival and demyelination are still poorly understood.
Previous studies have identified a myriad of extracellular cues and OL cell surface receptors that mediate OL
survival and differentiation but the intrinsic pathways that link these trophic cues to downstream events remain
elusive. In my preliminary studies, I made a striking discovery by identifying Transcription Factor EB (TFEB) as
the missing link. I discovered that TFEB is highly expressed by OL lineage cells in the CNS including the optic
nerve. I generated a novel TFEB conditional mouse line and showed that in the mouse brain TFEB powerfully
antagonizes myelination by specifically promoting premyelinating OL cell apoptosis and simultaneously
inhibiting OL maturation. I developed a live-imaging based assay to model in vivo OL development, and
demonstrated that TFEB directly regulates gene expression of the integrated stress response and GPCR-PKA
pathways, two critical pathways previously implicated in demyelinating diseases. Based on these findings, I
propose to test the hypotheses that TFEB serves as the critical sensor in premyelinating OLs that facilitates
cell apoptosis in the absence of axonal contact or trophic support, and that extracellular signals modulate
TFEB expression/activity through the GPCR-PKA axis to control OL maturation, myelination, and remyelination.
I will utilize the rodent optic nerve as a model system to test these hypotheses. In my K99 phase I will
investigate TFEB function in optic nerve myelination during development and its roles in remyelination in optic
neuritis animal models, utilizing cell-type specific TFEB conditional mutants that I have already generated. I will
perform whole-genome RNA sequencing experiments to identify the candidate pathways that TFEB regulates,
and will further validate these pathways with the optimized in vitro culture system and the in vivo viral
manipulation toolkits. To assess the functional efficacy of optic nerve remyelination and repair, I will acquire
expertise in animal visual behaviors and stereotaxic injection techniques from the mentoring labs. Finally, as
an independent investigator, I will employ unbiased genomic and biochemical approaches to identify the direct
gene targets and interacting proteins of TFEB. I will leverage K99 phase training in animal surgery techniques
and viral approaches to modulate TFEB function in promoting myelin repair, as well as the training in mouse
visual behaviors to assess visual function recovery in optic nerve remyelination. The proposed research will
characterize a novel pathway regulating optic nerve myelination and will determine the underlying mechanisms.
By developing new drugs that target the TFEB pathway, my goal is to lessen optic nerve damage and promote
remyelination and visual recovery in patients with optic neuritis and multiple sclerosis.
!

Public health relevance
Project Narrative Demyelinating diseases such as optic neuritis and multiple sclerosis cause myelin loss and malfunction of the nervous system with limited treatment strategies. The proposed project will characterize a novel pathway that powerfully regulates myelination and remyelination in the optic nerve, and will further address the underlying molecular mechanisms. This project will gain insights on a new strategy in treating demyelinating diseases by simultaneously promoting oligodendrocyte cell survival, maturation, and remyelination.